Exploring Opportunities for Tennessee Department of Agriculture to Prepare to Implement FDA Rule: Standards for the Growing, Harvesting, Packing, & Holding of Produce for Human Consumption

Exploring Opportunities for Tennessee Department of Agriculture to Prepare to Implement FDA Rule: Standards for the Growing, Harvesting, Packing, & Holding of Produce for Human Consumption Project Summary FDA's Regulation “Standards for the Growing, Harvesting, Packing, and Holding of Produce for Human Consumption” (Produce Safety Rule) offer science-based minimum food safety standards for the growing, harvesting, packing, and holding of produce, meaning fruits and vegetables grown for human consumption. As the Tennessee Department of Agriculture (TDA) has not previously administered a produce regulatory program of this kind, the infrastructure to do so must be developed. TDA has therefore proposed to add a dedicated Produce Specialist, Legal Counsel, and two field Produce Inspectors to existing staff resources to develop a produce farm inventory, regulatory foundation and a comprehensive inspection, compliance and enforcement program. TDA is also proposing a partnership with the University of Tennessee, Institute of Agriculture (UTIA) as a subawardee of this project to assist TDA in developing a strong education and outreach program, to educate and provide technical assistance to producers as well as training programs for regulatory field staff. TDA intends to use these resources to conduct preliminary research as to the current status of the produce industry in Tennessee, including how many farms and what types of produce operations are in place. A legal review comparing current state rules and regulations to the requirements of the Produce Safety Rule to identify gaps in requirements, and given the findings of industry research, develop a regulatory foundation to support a state Produce Safety regulatory program in support of the federal rule. The UTIA partnership will help TDA ensure that regulatory requirements achieve their goals of reducing foodborne illness risks to the public. The UTIA education and outreach program will assist producers in achieving compliance with requirements given their operational needs to maintain production. It expected all of these components will be necessary to build a robust produce safety system that will be sustainable beyond the life of the cooperative agreement project.

Public health relevance
Exploring Opportunities for Tennessee Department of Agriculture to Prepare to Implement FDA Rule: Standards for the Growing, Harvesting, Packing, & Holding of Produce for Human Consumption Project Narrative FDA's Regulation “Standards for the Growing, Harvesting, Packing, and Holding of Produce for Human Consumption” offer science-based minimum food safety standards for the growing, harvesting, packing, and holding of produce, meaning fruits and vegetables grown for human consumption. The resources generated by this project will build an informed regulatory foundation for the Tennessee Department of Agriculture and a strong education and outreach program for the University of Tennessee, Institute of Agriculture. These elements will make the goals of the Produce Safety Rule possible, and subsequently better protect the integrity of the food supply in Tennessee.